Protecting Native Families from COVID-19: Radx Initiative

PROJECT SUMMARY
White Mountain Apache-Navajo-JHU research partners are uniquely positioned and prepared to advance COVID-19
prevention science through the Emergency Competitive Revisions for Community-Engaged Research on COVID-19
Testing among Underserved and/or Vulnerable Populations (NOT-OD-20-121). Since April 2020, we have implemented
comprehensive COVID-19 mitigation activities with Navajo and White Mountain Apache nations, who have had the
highest rates in the US, and honed capacity for home-testing and obtaining rapid results. Our experience and data
review with tribal divisions of health and the Indian Health Service has uncovered barriers to testing, protective
behaviors, isolation and care-seeking among two high risk sub-groups that must be addressed for successful
mitigation. The first group are elders, ages >65, who have the highest case fatality rate in both communities and are
deeply revered as teachers of cultural practices and languages. A significant portion of elders are currently resistant to
testing due to cultural beliefs and fear, and slow to seek care when symptoms worsen. The second group are young
adults, ages 18-34, using substances, who have the highest proportion of cases per capita, are less likely to social-
distance or isolate, and are more transient, moving among multi-generational households. This project will apply a 2x2
factorial design to evaluate two interventions for these high-risk groups: 1) a culturally tailored, age-specific
Motivational Interviewing (MI) intervention to promote testing, protective behaviors and appropriate isolation and
care-seeking, and 2) a COVID-19 symptom (CS) text-based monitoring system designed to shorten time between
symptom onset and testing, while incorporating GIS to assist with route-mapping for home-based follow-up. MI has
strong evidence in American Indian communities, including our team’s proven MI intervention for improved STI/HIV
testing. The CS System builds on our experience with mobile health surveillance and embedded GIS/GPS tracking. Our
three primary aims are: 1: Use Community Based Participatory Research to apply knowledge of relevant facilitators and
barriers to create, pilot, implement, and evaluate through an RCT a culturally tailored brief MI intervention to promote
COVID-19 testing when experiencing symptoms, appropriate preventive behaviors, and isolation and care-seeking when
positive among elders (ages >65 years) and young adults with a recent history of substance misuse; 2: Implement and
evaluate through a RCT a daily CS monitoring system with alerts, mechanisms for participants to request home-testing
when experiencing first symptoms, and GIS routing for those responding to text-based alerts; and 3: Evaluate the
relative merits of MI or CS alone or combined on testing and time to testing when experiencing symptoms, and
adherence to isolation and care-seeking recommendations when positive using a 2x2 factorial design. Our secondary
aims will explore if a) cultural identity and connectedness; b) substance use or mental health factors (depression,
anxiety, suicidality); and c) age and sex moderate intervention response. If aims are achieved, we will make rapid
advances in diagnostic testing strategies for the most underserved and high-risk populations in the US.

Public health relevance
PROJECT NARRATIVE Longtime tribal-academic research partners will evaluate two interventions--1) a culturally tailored Motivational Interviewing intervention, and 2) a text-based COVID-19 daily symptom checker—based on new data regarding facilitators and barriers to diagnostic testing and preventative behaviors among two high-risk American Indian age groups in communities hardest hit by COVID-19. They will use a factorial evaluation design to examine the relative clinical merits of each intervention alone or in combination. Minimizing time between first symptoms and testing/isolation is currently the most effective means to control the outbreak.